Role of miR-146a in Abdominal Aortic Aneurysm

Abstract
Abdominal aortic aneurysm (AAA) is a permanent dilation of the abdominal aorta with a high mortality
greater than 80% after rupture. Aortic vascular smooth muscle cells (SMCs) are pivotal in maintaining aortic
structural integrity and function, and SMC-rich aortic medial stability is highly disrupted in AAA. Currently,
besides surgical interventions, no alternative therapeutics are available to blunt AAA progression and rupture.
Consequently, there is a dire need to identify novel strategies for development of effective, non-surgical
therapeutics. MicroRNA-146a (miR-146a), a well-known regulator of inflammation and auto-immunity, is highly
expressed in aneurysmal tissue of AAA patients. However, the role of miR-146a in SMC homeostasis and
AAA remains to be explored. In preliminary studies, by in-situ hybridization, we observed that miR-146a is
upregulated in SMC-rich aortic media of human and mouse AAAs; miR-146a deficiency significantly promoted
Angiotensin II (AngII) -induced AAA formation in normolipidemic mice co-administered with Lysyl oxidase inhibitor,
β-aminopropionitrile (BAPN); and mimetics-mediated miR-146a overexpression abolished AngII-induced AAAs in
both hypercholesterolemic LDLr-/- mice and normolipidemic mice co-infused with BAPN. To elucidate underlying
mechanisms, by RNA sequencing, we identified novel targets from miR-146a deficiency experiments: TFIID-31,
a TATA binding protein associated factor involved in transcriptional activation and repression, is significantly
upregulated; whereas Beclin-1, a gene indispensable for autophagy induction and USP9X, a deubiquitinase
critical for Beclin-1 stabilization, are significantly downregulated. Autophagy, a self-regulatory process by
which cells digest, and recycle their cytoplasmic materials for energy purposes under stress. Our preliminary
study also showed an increased Beclin-1 in mouse AAAs, as observed in human AAAs and Tat-peptide
mediated Beclin-1 activation suppressed AngII-induced AAA formation in mice. In addition, miR-146a
overexpression significantly suppressed TFIID-31, promoted USP9X and Beclin-1, and ShRNA-mediated
silencing of TFIID-31 increased USP9X in cultured aortic SMCs. Based on these observations, we will test our
central hypothesis that miR-146a activation protects against AAA formation and progression by promoting
Beclin-1-mediated aortic SMC homeostasis. By utilizing our unique mice models generated specifically for
these studies, we propose 3 aims. Aim 1 will test our working sub-hypothesis that miR-146a promotes Beclin-1
stability in aortic SMCs via a TFIID-31-USP9X –dependent manner. Aim 2 will test our working sub-hypothesis
that miR-146a activation protects against AAA through activation of SMC-Beclin-1-derived autophagy. Aim 3
will determine the effect of miR-146a / Beclin-1 activation on progression of established AAAs. In summary, we
will delineate the protective role of Beclin-1 in AAA and establish miR-146a activation as a novel therapeutic
strategy against AAA by targeting SMC-Beclin-1. This mechanistic research will set solid preclinical evidence
that targeting miR-146a represents a novel therapeutic strategy for treatment and prevention of AAA.

Public health relevance
Project Narrative Abdominal aortic aneurysm, a permanent dilation of the abdominal aorta, with a high mortality rate of over 80% after rupture. Using novel mouse models that we have developed, our goals are to elucidate mechanisms responsible for AAA formation and identify new targets for therapeutic development against AAAs.